CTSA Predoctoral T32 Program at University of Rochester

The University of Rochester (UR) Clinical and Translational Science Institute (CTSI) T32 Pre-Doctoral Training Program aims to cultivate the next generation of leaders in translational science research (TSR). It encompasses a comprehensive mentored research experience, transdisciplinary educational opportunities, career development planning, and a supportive environment conducive to growth and achievement. Our training encompasses competencies across eight fundamental domains of a translational scientist (e.g. rigorous researcher, team player, boundary crosser, and population health champion), equipping trainees with the knowledge and skills needed to improve the health of patients and populations, and supporting the overall UR CTSI goals of advancing translational science by fostering Research Without Walls. Our specific aims are: Aim 1: Contribute to a well-trained clinical and translational science workforce by recruiting, mentoring, and immersing students into focused training opportunities across the translational science spectrum. We will form a coordinated learning community through structured collaborative coursework, research experience, translational science and regulatory science competitions, innovative academic challenges, and participation in professional development opportunities. Formal T32 training addresses TSR, population health, and bioinformatics and health analytics. Aim 2: Develop a heterogeneous Trainee pathway and stimulate interest in clinical research training and career paths. Integral components are targeted recruitment efforts, including summer research programs for undergraduates, tailored mentorship programs, and integration with UR CTSI undergraduate and Master’s programs. Aim 3: Ensure a safe and supportive research training environment through evidence-based mentor training and evaluation. T32 trainees will be mentored by a tailored structure consisting of multi-disciplinary faculty teams. We prioritize formal mentor training through our Ever Better Mentoring course, and we will implement a responsive evaluation approach that includes data-driven assessments and regular review of Trainee outcomes. Aim 4: Promote exploration of translational training and careers by leveraging institutional and CTSA Consortium resources and engaging with alumni. We will intentionally engage University faculty, former faculty, alumni, current and previous CTSI TL1/T32 and KL2/K12 Trainees, student organizations, and students and researchers across the CTSA Consortium to facilitate scientific and professional networking. The UR CTSI T32 Pre-Doctoral Training Program is the foundation of a research education ecosystem that reaches beyond the UR CTSI to leverage resources and faculty expertise across the institution, facilitating Trainee transformation from student to translational scientist. It is closely integrated with the K12 program and UM1 Workforce Development Element D through shared and integrated governance structures, CTSI services and a shared mentor base.

Public health relevance
The University of Rochester's Clinical and Translational Science Institute's T32 Pre-Doctoral Training Program aims to train the next generation of translational science leaders. It provides a comprehensive mentored research experience, transdisciplinary educational opportunities, career development planning, and an innovative and supportive environment. The program focuses on recruiting, mentoring, and immersing students into clinical and translational science research.